Developing and characterizing sleep-based network homeostasis in a diurnal rodent model for Familial Natural Short Sleep

Abstract:
Despite the importance of sleep for brain health, some people have a recently recognized condition called
Familial Natural Short Sleep (FNSS) where individuals sleep 4-5 hours per night but without health deficit.
Several human mutations causing FNSS have been identified and introduced in mouse genomes, but we do
not understand how this mutation enables less sleep need. However, while in humans the mutations result in
20-30% reduction of sleep at night, the same mutations in nocturnal mice had subtle (~6%) or no effects in the
amount of sleep, especially in the light phase when mice are predominantly sleeping. Given that FNSS genes
such as Dec2 are circadian clock modulators, an FNSS mutation in a diurnal model may better recapitulate the
human FNSS phenotype and can better model human sleep and circadian interactions. Here we propose to
develop a diurnal FNSS model to study the impact of sleep on homeostasis of neural network function, using
state-of-the-art behavioral and electrophysiologic methods. The fact that the grass rats share diurnality with
humans can render them a particularly powerful system for the study of sleep and circadian health. We expect
that since our grass rat model shares diurnal circadian drives with humans, our findings will offer substantial
new strengths in modeling human FNSS. Leveraging the recently available grass rat genome and CRISPR, we
have generated multiple genome-edited lines of grass rats and are in the process of developing a line carrying
the Dec2-P384R mutation. To measure sleep action on neural networks, the Watson lab has developed multiple
metrics based on multiple, single-unit electrophysiologic recordings. First, we published that spike rates and
spike rate variance drop over sleep, and preliminary data suggest that excitatory-inhibitory balance, burst firing,
and synchrony are also modulated by sleep/wake and circadian rhythms. These measures are defined as
“electrophysiologic background state” (EBS) and can be represent a novel but research-informed approach to
quantifying overall network status. To understand FNSS and normal sleep effects on the brain, it will be key to
establish how sleep in the Dec2-P384R mutation modulates these EBS metrics. Our central hypothesis is that
faster homeostatic attenuation of EBS measures per unit time in sleep enables/underlies healthy brain function
despite the shorter sleep duration in FNSS. Aim 1 of this study: Determine the impact of FNSS Dec2-P384R
mutation in circadian behavior and sleep state occupancy in this new mutation in diurnal grass rats. Aim 2:
Measure differential effects of sleep and wake on mutant versus FNSS using neural network functional
recordings. This will create a new research model encapsulating more human-like relationships between sleep
and circadian rhythms. Aim 2 will already establish novel understanding of sleep action on neural networks. In
the future, these animals can enable study many aspects of modern life including but not limited to 1) chronic
sleep deprivation, 2) irregular light schedule for shiftwork-like models, 3) chronic stress and other mood
disorders.

Public health relevance
Narrative: The proposed research will elucidate the neurobiological mechanisms underlying Familial Natural Short Sleep, which is relevant to public health because it will substantially increase our understanding of how sleep efficiency is regulated at the level of neural network. This knowledge will contribute to the development of more effective therapeutic and preventive strategies in mental health issues and neurological disorders associated with sleep deprivation, which is common in our modern society. Therefore, the proposed research is relevant to the NINDS and NIMH’s mission that aims to reduce the burden of neurolopsychiatric disease and to transform the understanding and treatment of mental illnesses through basic research.